Regulators of adipocyte oxidative metabolism

PROJECT SUMMARY
Adipose oxidative metabolism is central to human health. Defects in adipocyte mitochondria are linked to
adipocyte dysfunction and insulin resistance, whereas lifestyle interventions and pharmacological agents
that promote adipocyte oxidative capacity promote metabolic health and insulin sensitivity. Studies over
several years have identified important regulators of adipocyte oxidative metabolism, such as members
of the PGC-1 coactivator family, and nuclear receptors of the PPAR (peroxisome proliferator-activated
receptor) and ERR (Estrogen-related receptor) subfamilies. These transcription factors exert their effects
on gene expression and cellular function by both direct and indirect regulation of hundreds of genes that
coordinately promote mitochondrial biogenesis and oxidative metabolism. Mining of genes regulated by
PGC-1s and ERRs, coupled to bioinformatic approaches to determine associations of PGC-1/ERR
targets with PPAR pathways and metabolism, has led us to identify a new and poorly characterized
protein, Mcrip2, as highly associated with adipocyte oxidative metabolism. The premise of this proposal
is that Mcrip2, a protein of unknown cellular and molecular function, that has not been linked yet to
metabolism or physiology, is induced by PGC-1, PPAR and ERR factors, acts to enhance basal and
adrenergically stimulated expression of oxidative metabolism genes, and is thus a critical element of the
regulatory networks that control adipocyte oxidative metabolism. Interactions of Mcrip2 with proteins
involved in mRNA processing and turnover suggest that Mcrip2 exerts its function by regulating gene
expression at the post-transcriptional level. Notably, we know little about mechanisms controlling post-
transcriptional steps in adipocyte oxidative metabolism pathways. The proposed work will define the role
of Mcrip2 in adipocyte basal oxidative metabolism and adrenergic responses, using gain- and loss-of
function approaches in primary brown and inguinal adipocytes, and delineate the level at which Mcrip2
impacts gene expression. It will also determine the physiologic significance of Mcrip2 for mitochondrial
function and adaptive thermogenesis, using a mouse model. Finally, the studies will elucidate the
mechanism by which Mcrip2 impacts adipocyte biology, by defining Mcrip2 protein domains required for
function and critical Mcrip2 interacting partners in basal and adrenergically stimulated adipocytes. In
sum, the work will give first insights into post-transcriptional regulation of adipocyte oxidative function,
and may suggest new targets and avenues for therapeutic intervention in diseases that can benefit from
increases in oxidative capacity, such as obesity and obesity-related diseases.

Public health relevance
NARRATIVE Loss of mitochondria and oxidative capacity have been implicated in the development or progression of many diseases, from type 2 diabetes to cardiovascular diseases and skeletal muscle diseases. Understanding the mechanisms by which adipose cells respond to physiological signals, such as adrenergic stimulation, to build more mitochondria and higher capacity to oxidize nutrients, can present new ways for intervention in diseases associated with decreased oxidative capacity.